Epigenomics Core

Project Summary (Epigenomics Core)
The Projects of this Program include research strategies involving a variety of genome-wide profiling assays of
cancer cell epigenomes and transcriptomes at bulk and single-cell resolution. They also require the use of
sophisticated analysis approaches to separate the signal from the noise, extract biological information, and
integrate data across experiments and projects. The primary objective of the Epigenomics Core is to support the
P01 Projects with expertise in epigenetic profiling and analysis. The specific aims of the Epigenomics Core
achieve this by providing the Program with the key experimental and computational capabilities required to meet

Public health relevance
Project Narrative (Epigenomics Core) This program project aims to understand neuroendocrine plasticity and to utilize this knowledge for the design of new therapeutic strategies. The Epigenomics Core will provide experimental and computational tools and expertise to meet the essential needs of the Program.